Biomarkers Core RC3

RC3 Project Summary
The goal of the RC3 Biomarkers and Preclinical Core is to provide UConn Pepper Center (OAIC) trainees, pilot
and developmental project investigators and the broader scientific community with expertise and tools needed
to interrogate biomarkers, drivers of aging and underlying mechanisms of chronic diseases in humans and
animal models in order to promote function and independence in late life. Research supported by RC3 will
advance these UConn OAIC goals by emphasizing approaches derived from precision gerontology, our thematic
focus. To that end, RC3 will emphasize approaches and technologies capable of defining biological
heterogeneity in a manner that can lead to biomarker discovery and improved targeting of interventions. RC3
will offer investigators guidance with coordinated access to existing UConn Health and Jackson Lab cores and
resources. For investigators lacking deep familiarity with specific methods, advice and assistance will be offered
in terms of project development to determine best approaches, assays and analyses for their proposed studies.
RC3 will also provide biomarker analysis for all human subjects who participate in UConn OAIC studies. The
Specific Aims are: (1) Assist investigators in the development of experimental protocols involving biomarkers of
aging and related conditions such as chronic diseases, resilience, frailty and disability to achieve the goals of
each project; (2) Facilitate interaction between investigators, established core facilities and RC2 Data Resource
Core in order to achieve the goals for evaluating biological heterogeneity in each project; (3) Development of a
biobank and biomarker discovery.

Public health relevance
RC3 Project Narrative The RC3 Biomarkers and Preclinical Core will provide investigators (UConn OAIC scholars, developmental and pilot project investigators and the broader scientific community) with expertise needed to interrogate drivers of aging in humans and animal models related to diseases of aging and disability in order to further their studies of precision gerontology. The Core will assist investigators in development of protocols, facilitate interactions between investigators and established UConn and Jackson Laboratory for Genomic Medicine cores and facilitate data analysis and biomarker discover in conjunction with RC2 Data Resource Core.